Functions and mechanisms of new components in RNA silencing

The long-term goal of the PI Zhang’s laboratory is to decipher intertwined regulatory layers and
mechanisms that control RNA silencing and processing, and to eventually manipulate the regulatory
components and pathways in biotechnological applications. Here this proposal is to describe how the PI Zhang
will investigate unknown mechanisms and regulations of several newly identified components within two
master regulatory hubs centered on Serrate (SE) and Suppressor of Gene Silencing 3 (SGS3) for RNA
silencing in Arabidopsis. RNA silencing clears endogenous and invasive transcripts, and this process is
directed by microRNAs (miRNAs) and small interfering RNAs (siRNAs) in eukaryotes. MicroRNAs are
produced from hairpin-structured primary miRNA substrates (pri-miRNAs) by microprocessor that comprises of
Dicer-like protein 1 (DCL1), dsRNA binding protein 1 (DRB1), and SE. By contrast, siRNA production entails
the initial conversion of single-stranded (ss) RNA to double-stranded (ds) RNA via a complex composed of
RNA-dependent RNA polymerase 6 (RDR6) and SGS3 before its entry into DCL4/DRB4 complex. Since levels
of miRNAs and siRNAs are critical for their proper functionality in biology, the processing and accumulation of
small RNAs need to be tightly controlled. In research area 1, the PI Zhang will study how the components in
the SE-centered hub regulate miRNA production. Briefly, the PI Zhang laboratory has recently discovered that
RNA secondary structure (RSS) of pri-miRNAs can be remodeled to regulate DCL1/HYL1 activity. Importantly,
several RNA helicases (RHs) have been newly recovered from the hub, but how they sensor and re-wire RSS
of pri-miRNAs to control miRNA production is unknown. Furthermore, extensive preliminary data also identify
key connections between reactive oxygen species (ROS) and microprocessor components that modulate
miRNA production. Thus, the PI Zhang will systematically investigate the novel functions and mechanisms of
the RHs and catalases from SE hub in miRNA biogenesis in Area 1. In research Area 2, the PI Zhang
focuses on the major gap in the siRNA production that is how ssRNA substrates are specified and loaded onto
SGS3/RDR6 for dsRNA synthesis. Through a newly developed genetic screening, numerous novel
components exemplified by U1-70K and BICE1 among others have been recovered to be engaged in siRNA-
mediated RNA silencing. Remarkably, the components interact with RNA polymerases in nucleus and
ribosomes in cytoplasm as well as the shared SGS3 protein. In this setting, the PI Zhang would
comprehensively study how these factors help SGS3 to fetch the nascent transcripts from chromatin, and to
set up the platform for SGS3/RDR6 nearby ribosomes to synthesize dsRNAs. The proposed study will not only
reveal new regulatory layers and mechanisms of RNA silencing, but also enable us to explore the highly
conserved components to control small RNA production and activities in biological processes, and to
eventually to cure physiological disorders that arise from dysfunctions of RNA processing in biotechnology.

Public health relevance
RNA silencing regulates essentially every biological process in eukaryotes, and their dysregulations causes numerous diseases and physiological disorders in human and in plants. The proposed study is to determine how several newly identified components such as RNA helicases, catalases, U1-70K, and BICE1 contribute to the production of small RNAs for RNA silencing in Arabidopsis. The studies on the new regulatory mechanisms in RNA silencing in the model organism Arabidopsis may enable us to manipulate these components for a better therapeutic strategy to cure physiological disorders that arise from dysfunctions of RNA processing in biotechnology.